Addressing the Intimate Partner Violence and HIV Syndemic in Kampala, Uganda: Implementation Science for Intervention Optimization and Adaptation

ABSTRACT:
This application outlines an interdisciplinary, implementation science project related to the integration of intimate
partner violence prevention and HIV care that will support the F31 applicant to complete dissertation
requirements for an Implementation Science PhD through the Department of Global Health at the University of
Washington. The applicant's goals for training include building skills for advanced quantitative and qualitative
research design and analysis; reinforcing multidisciplinary training approaches; deepening training in responsible
conduct for international research and, developing publication record and presentation skills. To achieve these
goals, the applicant has assembled a team of mentors with expertise in intimate partner violence, HIV treatment
and prevention, implementation science, behavioral sciences and epidemiology. Mentorship team members
have established track records of collaboration and mentoring PhD candidates. The novel proposed research
will leverage the Sponsor's ongoing NIMH-funded project entitled “Integrated PrEP and ART delivered in
Ugandan public health clinics to improve HIV and ART outcomes for HIV serodiscordant couples”
(R01MH110296; PI:Heffron), an ongoing couples-based, integrated ART/PrEP (pre-exposure prophylaxis)
delivery intervention in Kampala, Uganda. This F31 proposal outlines research involving HIV care and treatment
facilities and providers engaged with this parent study to collect novel data in order to guide the development of
optimized implementation strategies for concurrently targeting the co-occurring and intersecting global health
challenges of HIV and intimate partner violence (IPV). This project will inform the optimization and adaptation of
integrated service offerings for IPV and HIV treatment and prevention in limited-resource settings. To this end,
the proposed F31 research will leverage quantitative, qualitative and implementation science research
approaches to elaborate strategies for optimizing and adapting implementations that address the IPV/HIV
syndemic and better characterize the complex association between IPV and HIV within the context of couples.
Aim 1 will evaluate the extent to which national IPV guidelines are implemented in HIV care settings. Aim 2 will
identify provider-level barriers and facilitators to implementing national IPV guidelines in HIV care settings. Aim
3 will evaluate the association between IPV and adherence to ART and PrEP among HIV-serodiscordant
couples. Upon achieving the proposed aims, the F31 applicant will be well-suited to pursue a career in academic
research and prepare proposals to further the development and testing of couples-based interventions that
integrate IPV prevention and treatment into existing HIV prevention and treatment programs.

Public health relevance
PROJECT NARRATIVE Intimate partner violence and HIV represent interconnected challenges to global health and there is a need to optimize and adapt evidence-based implementation strategies that target this syndemic in order to reduce morbidity and mortality related to both IPV and HIV. There is a gap in the existing evidence base articulating implementation effectiveness and challenges of implementing integrated IPV/HIV services. The proposed scope of work will leverage techniques of implementation science research to assess individual and facility-level qualitative and quantitative data and develop strategies that concurrently address challenges of IPV and improve HIV-related treatment and prevention outcomes for individuals and HIV-serodiscordant couples.